Functional genomics approaches to decode the roles of transcription factor isoforms

PROJECT SUMMARY
The overall goal of this proposal is to systematically characterize the cellular functions of
transcription factor isoforms. Transcription factors (TFs) are master regulators of gene expression and as
such play key roles in a variety of biological processes, including cell growth and differentiation. The human
genome is estimated to harbor ~1600 TF genes; however, most of these are expressed as a series of protein
isoforms arising from mRNAs with alternative starts, ends, or splicing. Though a handful of alternative TF
isoforms are known to play functionally important (and distinct) roles in the cell, the overwhelming majority—
thousands of proteins—remain entirely uncharacterized. Moreover, splicing aberrations are a hallmark of
cancer, and mis-expression of TF isoforms can contribute to tumorigenesis. Thus, decoding the roles of TF
isoforms is key to a systems-level understanding of gene regulatory networks (GRNs) in development and
disease. In my previous work, I found widespread changes in DNA binding, protein-protein interactions, and
transcriptional activation in exogenous assays across a collection of >700 TF isoforms. These results
underscore the need to perturb and characterize TF isoforms in their endogenous cellular context to truly
understand their roles in GRNs.
Functional genomics approaches such as high throughput perturbation screens have revolutionized our
understanding of gene functions. I aim to apply and extend these functional genomics approaches to
study isoforms, which have remained elusive due to technical limitations. I propose to use a combination of
state-of-the-art genomic technologies to decode the functions of TF isoforms in breast cancer cells. I will
leverage long read RNA-sequencing to perform rigorous isoform-aware analyses (Aim 1) and isoform-specific
high throughput experiments (Aims 2 and 3). In Aim 1, I will re-analyze existing CRISPR/Cas9 knock-out
databases from the Cancer Dependency Map Consortium to identify candidate isoform-specific phenotypes in
breast cancer. In Aim 2, I will establish a platform for robust and specific knock-down of individual isoforms in
mammalian cells using RNA-targeting CRISPR/Cas systems. In Aim 3, I will use tunable libraries of TF ORFs
to quantitatively tune isoform expression across a range of physiological levels. The proposed work includes
technology development in the mentored K99 phase, which I will then leverage during the independent R00
phase to probe the mechanisms of TF isoform function in breast cancer via single-cell screening approaches.
Successful execution of these aims will begin to decode the “dark matter” of alternative TF isoforms,
laying a foundation for future studies of alternative isoforms more broadly. By combining new training in high-
throughput screening approaches during the K99 phase with my existing expertise in gene regulation, TF
biology, and bioinformatics, this transition to independence award will position me well to start my own
research group that uses interdisciplinary genomic methods to probe GRNs in development and disease.

Public health relevance
PROJECT NARRATIVE Transcription factors are proteins which play key roles in a variety of biological processes and many human diseases, including cancer. Most transcription factors are expressed not as a single protein, but rather as a series of distinct protein “isoforms”, yet the vast majority of transcription factor isoforms—thousands of proteins—remain entirely uncharacterized. The proposed project will develop approaches to probe the roles of thousands of transcription factor isoforms at once in breast cancer cells, which will uncover novel disease- relevant biology and lay the foundation for studying isoforms more broadly, genome-wide and in other cellular contexts.